Acupuncture to Improve Outcomes in Patients with Sepsis: a Randomized Controlled Trial

PROJECT SUMMARY/ABSTRACT:
Sepsis is a life-threatening medical condition characterized by high levels of inflammatory markers
and multi-organ damage. Despite standard treatment, sepsis remains a leading cause of morbidity
and mortality in critically ill patients, especially cancer patients. Recently, it has been shown that
acupuncture can induce dopamine production, suppress inflammation, and reduce sepsis in animal
studies. Several randomized controlled clinical trials have shown that acupuncture may reduce
mortality in sepsis patients. However the trials were unblinded and at risk for bias. Here we propose
to fill the knowledge gap by conducting a randomized controlled, patient and evaluator blinded, phase
2 trial of acupuncture (the ACTIONS trial), using sham acupuncture as control, in patients at risk for
sepsis. The specific Aims are: 1) to generate preliminary data for the estimated effect size of
acupuncture in reducing mortality and ICU (Intensive Care Unit) admission of sepsis patients and to
determine the feasibility of conducting a randomized controlled trial of acupuncture in hospitalized
patients who are at risk for sepsis; and 2) to explore whether acupuncture increases catecholamines
and reduces inflammatory cytokines more than sham acupuncture. Seventy-eight patients at risk for
sepsis, will be randomized to true or sham acupuncture daily for 10 days or until transfer to ICU,
death, or discharge. Feasibility endpoints include as accrual rate, intervention delivery rate, attrition
rate, and data completion rate. Efficacy endpoints include mortality and rate of ICU admission.
Biomarker endpoints are plasma levels of catecholamines and pro-inflammatory cytokines, measured
before and after the first acupuncture treatment. If this study shows that acupuncture is deemed
feasible and the estimated effect size warrant a larger study, we plan to conduct a randomized
controlled phase 3 study evaluate the definitive efficacy of acupuncture in improving outcomes of
sepsis patients. The proposed study would be the first one acupuncture study on sepsis using sham
acupuncture as control. The data will also shed light on the mechanism of action of acupuncture. This
project has the potential of developing acupuncture as an innovative clinical approach in the
management of sepsis. It challenges the current clinical practice paradigm and can lead to reduction
of deaths due to sepsis.

Public health relevance
PROJECT NARRATIVE Sepsis is a major cause of death among immune-compromised cancer patients such as those undergoing chemotherapy. The proposed study investigates acupuncture, a novel modality in management of sepsis, for its role in reducing death or intensive care unit admission among those patients. This research can potentially give us a new tool for how we prevent and treat sepsis, a common treatment-related toxicity in cancer patients.